Preclinical Medications Screening in Mouse Models of Alcohol Dependence

The contractor is to perform blind testing of compounds using standardized preclinical models of AUD and to provide analyses and write-ups of said testing. Technical requirements include Compound Related Activities (Compound Testing, Compound Storage and Administration, Data Analysis and Reporting, Data Recording, Data Maintenance and Storage); Animal Welfare; Project Management; and Reporting and Deliverable Requirements.